Phase I Trial of Radiation and Lenalidomide in Pediatric Malignant Glioma

This study remains open to accrual. Brain tumors are the most common solid neoplasm in childhood and the second most common group of pediatric cancers. Standard therapeutic options for brain tumors consist of surgical resection, radiation therapy and chemotherapy; yet overall survival rates for malignant brain tumors remain low. Radiation therapy plays a key role in the treatment of diffuse intrinsic pontine gliomas (DIPG) and high-grade gliomas (HGG), and thalidomide has been shown in an animal model to be a radiosensitizer. Lenalidomide, a thalidomide analog with antiangiogenic, cytotoxic and immunomodulatory effects, is being evaluated for the treatment of CNS tumors, and has shown tolerability and activity in pediatric studies. Objectives: To determine the tolerability and toxicity profile of oral lenalidomide when administered to children with newly diagnosed HGG and DIPG with concurrent radiation at doses up to 116 mg/m2/day. To evaluate long-term tolerability of lenalidomide in children with newly-diagnosed HGG and DIPG To evaluate magnetic resonance imaging (MRI) sequences for noninvasive monitoring of metabolic and biologic changes in malignant brain tumors with therapy. To estimate 6 month and 12 month progression free survival (PFS) and overall survival (OS) in this patient population. To determine if angiogenic and/or immunomodulatory biomarkers in the blood and urine correlate with toxicity and disease response. To determine the rate of CNS metastatic disease in patients treated with antiangiogenic chemotherapy. To determine any correlation of steady state pharmacokinetics of lenalidomide with time to progression, number and type of toxicities, and dose limiting toxicities. Eligibility: Children with newly diagnosed HGG or DIPG,less than 21 years of age, no prior chemotherapy or radiation therapy, and performance score greater than or equal to 60%. Children with HGG must have an inoperable or incompletely resected tumor. Clinical laboratory tests must be within stated limits. Design: There will be two phases to therapy on this study, the Radiation Phase and the Maintenance Phase. The MTD will be determined by tolerability during the Radiation Phase. Eligible patients will receive radiation therapy five days per week to a prescription dose of 54-55.8 Gy, with concurrent administration of lenalidomide daily in a standard Phase I dose escalation design. At the conclusion of radiation therapy, there will be a two week break followed by maintenance dosing of lenalidomide for 21 days of a 28 day course, until unacceptable toxicity, disease progression or completion of 24 courses of lenalidomide beyond radiotherapy. Using a standard phase I dose escalation design, the total sample size and the study duration are expected to be 18 30 patients and 5-6 years, respectively.